Modernization of Zebrafish Core Facility

PROJECT ABSTRACT: Modernization of Zebrafish Core Facility
The Zebrafish Core Facility at Albert Einstein College of Medicine (Einstein) provides investigators access to
utilize zebrafish as an in vivo model for a variety of applications such as disease modeling, drug testing and
screening, and whole organism intravital imaging. The facility currently offers services to maintain established
transgenic and mutant zebrafish lines, provide 100’s of embryos per week, and to rapidly produce new transgenic
or mutant animal strains. The first aquatic system of the facility housed was established in 2001 and is still in
usage today. Much has changed in zebrafish maintenance and husbandry standards in the field. Thus, we have
identified a major need to upgrade this aging system. We plan to update to a state-of-the-art life support system
with pH, conductivity, and total dissolved gas monitoring and dosing systems, rotating microscreen drum filter
and centralized sump, and new tanks with locking lids to prevent escaping zebrafish. In addition, zebrafish
research programs have significantly expanded and diversified since 2001. Our current facility is poorly outfitted
to expand into some of these new scientific directions. We have identified a need to provide Einstein researchers
with access to technological advances to enable them to enrich their research programs in a variety of directions.
The proposed addition of three stand-alone housing systems that permit environmental modifications unique to
each housing system will provide added flexibility for new experimental approaches. For example, using
zebrafish as personalized avatars for human cancer cell xenografts will allow rapid in vivo drug screening to
identify tumor-specific vulnerabilities. Other examples are the exploration of how different diets impact immune
responses and cancer growth or in vivo toxicology. The three new stand-alone systems with customized tanks
and environmental controls proposed in the application will allow the facility users to perform these specialized
experiments without impacting the larger breeding zebrafish colony housed in the main system. These advances
will greatly expand the services available to Einstein zebrafish users.

Public health relevance
PROJECT NARRATIVE: Modernization of Zebrafish Core Facility Zebrafish is a highly malleable vertebrate model used by scientists around the world to model human health. To support robust and reproducible research and increase the capabilities of zebrafish scientists at Albert Einstein College of Medicine, we propose a full upgrade and modernization of our Zebrafish Core Facility. This is relevant to public health because it will allow investigators to dissect disease-causing pathways.